Molecular basis for microtubule-destabilization dependent MYB degradation

Project 2 Abstract
MYB is a master transcription factor in hematopoiesis, a recurrently translocated oncogene, and a selective
dependency in leukemia. Following a report that microtubule destabilizing agent (MDA) mebendazole powerfully
and selectively induces degradation of the MYB protein, we demonstrated the same effect in structurally diverse
MDAs. Using proteome-wide mass spectrometry and genetic screens, we found that MDA-induced MYB
degradation is fully rescued by proteasome or E1 ubiquitin ligase inhibitors, and identified MAP3K1 as the E3
ubiquitin ligase required for MDA-dependent MYB degradation. Strikingly, MAP3K1 is unique among E3 ubiquitin
ligases in having a tubulin binding domain in addition to ubiquitin ligase and kinase domains.
Our laboratory has identified several mechanisms of drug-induced degradation of hematopoietic transcription
factors. We found that thalidomide derivatives act as molecular glues to induce degradation of IKZF1 and IKZF3
by the CRBNCRL4 E3 ubiquitin ligase, a finding that explains the activity of these drugs in multiple myeloma. 1-3
Subsequently, we described a mechanism of drug-induced polymerization and degradation of BCL6, enabling a
novel therapeutic approach for lymphomas. 4 These mechanisms of drug-induced protein degradation rely on
interactions that do not occur physiologically. MYB-induced degradation is different, as multiple biochemically
distinct mechanisms of destabilizing microtubules induce MYB degradation. For this reason, elucidation of the
mechanism linking microtubule polymerization with MYB stability has implications for both drug activity and the
normal physiological link between microtubule destabilization and MYB activity. We hypothesize that the link
between MYB stability and microtubule polymerization will reveal a novel mechanism of transcription factor
regulation through microtubule-dependent regulation of MYB stability, cellular localization, protein-protein
interactions, and transcriptional activity.
We now propose to elucidate the mechanism and biology of MDA-dependent MYB degradation, which may have
implications both for cancer drug development and for the regulation of hematopoiesis. In Specific Aim 1, we
will dissect the activity of MAP3K1 activity, evaluating its domain structure, microtubule-dependent protein-
protein interactions, and ubiquitin ligase activity. In Specific Aim 2, we propose to dissect MYB structure-
function, elucidating the critical amino acids for degradation and leukemia-dependent cell killing, including
mutations that cause resistance to MDA in MLL-AF9 leukemia models. In Specific Aim 3, we will investigate
the biological connections between microtubule polymerization, cell cycle, and MYB activity. We will investigate
the implications of these findings for the role of MDAs in normal hematopoietic progenitor cells and in MYB-
dependent leukemia cells.

Public health relevance
Project Narrative – Project 2 Recent reports reveal that MYB, a key protein that promotes the development of leukemia, is degraded by mebendazole, a microtubule disrupting agent. We aim to clarify the process by which MYB degradation is linked to microtubule stability, and how it responds to this class of medications that is widely used but not well understood. Here, we propose a set of studies to dissect the molecular basis for MYB degradation in response to microtubule destabilization.